Core B: Bioinformatics & Biostatistics Core

PROJECT SUMMARY
Recent advances in single cell RNA-seq (scRNA-seq) technology have enabled quantification of underlying
heterogeneity within cell populations through identifying gene expression signatures of individual cells to reveal
transcriptionally distinct cellular subsets. In addition, scRNA-seq combined with appropriate bioinformatics
analyses enable modeling of developmental lineage hierarchies and discovery of rare cell types that would be
otherwise masked in bulk RNA-seq data. Comprehensive and systematic analysis of both scRNA-seq and bulk
RNA-seq data is critical to the success of the Research Projects (RPs) in this Program. The Bioinformatics and
Biostatistics Core (Core B) has been designed to meet this need. The Core B leader (Dr. Stephen Yi) has over
10 years of experience in research and teaching in bioinformatics and biostatistics, especially in gene expression
analysis, resulting in more than 30 high-impact publications in the field. Core B services will be used by all three
RPs for bioinformatics analysis of scRNA-seq and bulk RNA-seq data on mouse and human (with Core C) TECs,
stromal cells, and HAPCs. The Core will also provide biostatistics support for all experiments in the Program.
The analytical approaches provided by Core B are essential to the goals of all RPs. The core will provide services
in three Tasks for the RPs as follows: Task 1. Data storage and maintenance for all Research Projects (RP) and
Cores; Task 2. Perform gene expression analyses on scRNA-seq and bulk RNA-seq data; Task 3. Provide
general biostatistics support for data generated from RP 1, 2, 3 and with Core C.
The Core B leader will interact frequently with RP and Core C leaders to discuss experimental goals and
devise strategies for effective bioinformatics and biostatistical analyses. Successful delivery of Core B services
will greatly facilitate the overall program through: (i) serving as a key link of overall program synergy; (ii) mapping
transcriptional changes in cells of the human and mouse thymus microenvironment over the perinatal to juvenile
transition; and (iii) identifying candidate molecular mechanisms that may play a role in the differential functional
potential of cells in the perinatal versus juvenile thymic microenvironment.